Network of the National Library of Medicine Region 1 Administrative Core

Region 1 Administrative Core Summary/Abstract
The University of Maryland, Baltimore (UMB) RML Team leads a responsive outreach and engagement program that addresses the emerging needs of a large region.
Built on experienced leadership, highly-skilled coordinators and seasoned support staff for fiscal responsibility, the RML is supported by a governing body of four advisory groups. The make-up of Region 1 NNLM members who serve on the Senate, Library Advisory Board, Community of
Interest Leaders, and Executive Committee reflects regional membership and
guides the RML direction to:
• Shape the program and ensure that it is relevant, community-driven, and impactful.
• Support the mission of the NNLM and contribute to national goals.
• Help the RML meet network performance measures.
This member-centric governance structure supports the RML in cultivating thriving and engaged network membership.
The RML Team collaborates multi-regionally with other RMLs, and NNLM Offices and Centers to implement effective network membership recruitment strategies, maintain a continuation of operations plan that guarantees national and local service, and conduct program evaluation to guide, monitor, and continually improve RML and national programs.